Impacts of copy number variation on gene regulatory networks and fitness in Candida

Project Summary/Abstract:
The evolution of antimicrobial drug resistance is an urgent threat to public health. A better understanding
of basic evolutionary principles in microorganisms can inform efforts to identify, prevent, and combat the
emergence of drug resistance. Candida albicans, one of the most common fungal pathogens, can adapt to
antifungal drugs via mutations that alter gene expression levels. Gene expression levels can be altered by
changes in gene copy number and mutations that alter transcriptional regulatory networks. Basic science
investigating the influence of gene copy number changes on fitness and the impact on the gene regulatory
network across diverse genetic backgrounds is needed. These investigations will directly contribute to combating
the emergence of antifungal drug resistance.
The objective of the proposed research is to test the effects of copy number changes on fitness and gene
regulatory networks, and relate these effects to the rate and dynamics of the evolution of antifungal drug
resistance in C. albicans. In the long-term, this work can be extended to additional fungal pathogens and related
to clinical sampling data, as well as inform general evolutionary biology principles that can be tested and applied
across the tree of life. Aim 1 uses newly developed CRISPR-activation technology in C. albicans to test the
fitness effects of gene overexpression in multiple genetic backgrounds and environments. These data will be
used to describe the distribution of fitness effects of recurrently amplified genes. Aim 2 combines CRISPR-
activation technology with single-cell RNA-sequencing to model transcriptional regulatory networks. These will
be used to identify genome-wide transcriptional effects of gene amplification in diverse genetic backgrounds and
environments. Aim 3 uses experimental evolution to test the hypothesis that a gene’s position within the
regulatory network influences the rate and dynamics of adaptive gene expression change in resistance genes.
The long-term career goals of the candidate are to establish a research program centered around genetic
constraints and facilitations to evolutionary adaptation at a major biomedical research institution. The short-term
training goals of this proposal are to further develop the candidate’s expertise in the computational representation
of regulatory networks and in the application of single-cell RNA-sequencing technologies to pathogenic yeast.
The University of Minnesota provides an ideal environment in which to pursue these training goals, with excellent
resources for career development, extensive genomics and computing core facilities, and faculty with expertise
in genomic networks, evolutionary biology, and microbiology that will serve as mentors and advisors to the
candidate. The training and research proposed will launch the candidate into an independent and productive
research career.

Public health relevance
Project Narrative Pathogenic yeast that are resistant to antifungal drugs are a serious public health concern. To combat the evolution of drug resistance we need to understand the mechanisms by which copy number variants produce resistance and the pleiotropic effects they have on fitness and gene expression. Applying high-throughput CRISPR-based and single-cell sequencing technologies to assay fitness and gene expression across multiple genetic backgrounds will identify trade-offs that are robust to standing genetic variation and can be exploited for combination therapy and drug development.